Mapping Mental Health Emergency Response Systems: Assessing Capacity, Equity, and Impact Across the U.S.

Project Summary/Abstract
52 million individuals in the U.S. have mental health conditions. Fewer than half received treatment in
the past year. Research indicates the U.S. has an ill-equipped and maldistributed mental health emergency
response system (MHERS), stemming from underdeveloped infrastructure and a paucity of providers. Two key
components of the MHERS are acute psychiatric beds and emergency hotlines such as the national 988
Suicide and Crisis Lifeline (988).
The supply and distribution of MHERS resources throughout the U.S.—including psychiatric beds and
988 staffing—is poorly characterized. We propose to construct a longitudinal, nationally-representative
inventory of each state’s MHERS, providing us with timely information corresponding to three aims: first, to
quantify the evolving capacity of each MHERS, such that policymakers have up-to-date information on
prospective investments; second, to examine inequities in availability of MHERS resources according to
demographic and socioeconomic characteristics of local communities; and third, to relate geographic variation
in MHERS capacity to population health outcomes, including deaths by suicide and mental health-related
emergency department (ED) admissions. Over the project period, states including CA, TX, OH, and NY have
pledged more than $U.S. 6 billion to overhaul their MHERS, providing a natural experiment within our study by
which we can relate changes in MHERS capacity (i.e., number of psychiatric beds, 988 staffing) to population
health outcomes (i.e., deaths by suicide, ED admissions).
Achieving this effort depends on our ability to synthesize data from diverse primary and secondary
sources, including: (i) state licensure data on acute psychiatric beds, (ii) a national survey of facilities with
psychiatric beds to deduce characteristics such as bed occupancy rates and wait times, (iii) 988 metrics
curated by Vibrant Emotional Health (Vibrant), (iv) a survey of 988 call centers to document staffing, and (v)
data from secondary sources such as the Centers for Disease Control and Prevention’s National Vital
Statistics. We have worked extensively with all relevant datasets, and we have strong relationships with
agencies engaged in 988 metrics curation and 988 call center support. We also have deep experience
conducting national surveys (including on facilities with psychiatric beds and 988 infrastructure), and we have
led a prior statewide investigation of psychiatric bed capacity for California.
Ultimately, this study will provide real-time information to states about the magnitude and distribution of
shortages in their MHER systems. Corresponding to our third aim, we will also build a simulation model and
online user interface that allows public officials and policymakers to examine the degree to which investments
in their local jurisdictions would be expected to reduce ED admissions and deaths by suicide.

Public health relevance
Project Narrative The United States (U.S.) has an ill-equipped mental health emergency response system (MHERS), stemming from a lack of mental health treatment infrastructure and a paucity of providers. A comprehensive collection of data on the longitudinal capacity of each U.S. state’s MHERS—including available psychiatric beds and emergency response hotlines—is needed to identify gaps and opportunities for investments. In the proposed study, we will: (1) measure MHERS capacity throughout the U.S. such that policymakers have timely information on metrics to guide investments, (2) examine inequities in availability of MHERS resources according to geographic and sociodemographic population characteristics, and (3) relate variation in MHERS capacity to population health outcomes, including suicide deaths and mental health-related emergency department admissions.